Administrative Core

PROJECT SUMMARY/ABSTRACT
The goal of the revised COBRE Center for Applied Immunology and Pathological Processes is to
establish a nationally recognized advanced research and training program that facilitates the development of
junior faculty research toward major independent research funding in the research intersections between the
dysfunctioning of the immune response and disease pathogenesis. That is, we hope to grow Applied
Immunology as a discipline on campus because of its importance as a basic science, clinical science and a
translational science that can engage and synergize with all of the other centers on campus. Specifically, we
hope to focus on the understanding of abnormal immune responses with disease pathogenesis, such that we
provide a better understanding of how when the immune response is altered, immunopathology or disease
development ensues. This focused research area is in line with our current expertise and with our new
targeted junior faculty hiring plan (3 new tenure track faculty have been hired in 2019 that fit directly with the
COBRE application; additional positions will open in 2020). In order to accomplish this goal, a multifaceted
plan for research program development along with mentorship and training is required. The Administration
Core A will implement and manage all COBRE program initiatives including establishing advanced research
core facilities, establishing a mentorship program for junior faculty development, junior faculty development
workshops, establishing External and Internal Advisory Committees along with a Senior Mentoring
Committee, coordination with the External Research Specialists, establishing an annual scientific colloquium
and formal evaluation procedures, and establishing pilot grant mechanism that supports development of
promising projects from junior faculty. The Administration Core (Core A) will be managed by the COBRE PI
along with coordinator assistance, core management assistance, and business management oversight of the
program budget. This core will centralize all COBRE program documentation and reporting in compliance
with NIH COBRE requirements.